PTH POTENTIATION OF AII INDUCED ALDOSTERONE SECRETION

The purpose of this study was to determine whether PTH alone stimulates aldosterone secretion and whether it augments aldosterone secretion in response to AII.